PIKfyve regulation of IL-12 signaling in dendritic cells and cancer immunity

PROJECT SUMMARY/ABSTRACT
Since the discovery of the IL-12 cytokine, it has been considered a “master regulator” of the immune
system. Primarily produced by dendritic cells, IL-12 is the key signaling molecule linking innate to adaptive
immunity to drive IFN𝛾𝛾/Th1-mediated T cell responses against pathogens and cancer. Preclinical studies have
long shown that enhancing IL-12 signaling improves vaccines. Recently, IL-12 in dendritic cells was shown to
be required for anti-PD1 efficacy in mouse models of cancer. Despite the data nominating the IL-12 pathway
as a therapeutic target in cancer, previous attempts to directly administer IL-12 in clinical trials have resulted in
patient death from cytotoxic response or poor efficacy due to IL-10-mediated negative feedback. Subsequent
efforts in cancer have largely focused on improving methods to deliver and release IL-12 with limited success.
Therefore, there is a significant need to better understand the biology of IL-12 regulation in dendritic cells to
identify novel, safe and effective strategies of targeting this pathway as an anti-cancer strategy.
Our group previously identified PIKfyve lipid kinase as a novel target of the highly efficacious, well-
tolerated and orally administered multi-kinase inhibitor, ESK981. We demonstrated the ability of this drug to
reduce tumor growth in multiple syngeneic mouse models of cancer and enhance anti-PD1 therapy.
Interestingly, drug efficacy was dependent on the presence of CD8+ T cells, and the IL-12 and IFN𝛾𝛾 and
signaling pathways in vivo. Furthermore, ESK981 could directly enhance IL-12 signaling in primary dendritic
cells in vitro and in vivo through transcriptional regulation of IL12B.
Therefore, the overall goal of this project is to define the mechanism of IL-12 regulation by PIKfyve and
demonstrate the nature of PIKfyve inhibition, as an anti-cancer therapy, in anti-tumor immune responses. The
overarching hypothesis is that PIKfyve inhibition induces IL-12 signaling in dendritic cells to enhance antigen-
specific, CD8+ T cell responses in cancer. Experiments in Aim 1 will investigate the effect of Pikfyve
knockdown and conditional knock-out in mouse dendritic cells on the genes and protein subunits in the IL-12
signaling pathway in vitro and in vivo. To examine dendritic cell subsets, such as CD8α+ and CD103+ cDCs,
mice with genetic knock-out of Batf3 will be included for in vitro and in vivo studies. Experiments in Aim 2 will
study the potential anti-tumor effect of PIKfyve inhibitors, including ESK981and Apilimod, on dendritic cell
Pikfyve conditional knock-out, Batf3 knock-out, and wild type mice. We will monitor tumor progression and
examine T cell responses in the tumor draining lymph nodes and tumor microenvironment, including OVA
model antigen and neoantigen specific CD8+ T cell activation using tetramers available for the MC38 tumor
model. The proposed study will provide greater insight into the biology of IL-12 signaling in dendritic cells and
could provide the rationale for selecting PIKfyve inhibitors as safe, effective methods of enhancing IL-12 alone
and in combination with IL-12-dependent therapies, such as checkpoint inhibitors and vaccines in cancer.

Public health relevance
PROJECT NARRATIVE IL-12 signaling in dendritic cells is critical for anti-tumor T cell responses and response to immunotherapy but has been challenging to target therapeutically. More recently, PIKfyve inhibitors have been shown to affect IL- 12 signaling in dendritic cells and touted as promising drugs against cancer and infectious disease though further insight into the mechanisms of this regulation is needed. This research proposal will characterize the regulation of IL-12 by PIKfyve in dendritic cells and its effect on T cell effector responses to better understand its potential as a cancer therapy.